CHILDRENS CANCER GROUP

The objectives of this proposal are to support and enhance the current and future activities of New York University Medical Center (NYUMC) as a principal member of the Children's Cancer Group (CCG) by: (1) Improving the outcome for children with cancer through, a) continued patient entries at an increasing level to active CCG protocols, b) participation in leadership positions on CCG Strategy Groups and Discipline Committees so as to develop improved methods of treating childhood cancer, c) collaborating in the development of new studies by NYUMC investigators. 2) Developing new methodologies for the treatment of childhood cancer by, a) participation and leadership roles in Phase II studies and New Agent Phase I studies, b) piloting studies that have potential for incorporation into future CCG trials in selected disease entities such as brain tumors. 3) Improving the quality of life for survivors of childhood cancer and their families by, a) participating in CCG long-term effects studies, b) evaluating quality of life issues in children being treated for cancer, c) placing all eligible patients on open supportive care studies, d) continued participation in the cardiac intervention study conducted by the Children's Hospital of Philadelphia. 4) Active participation in biology studies by, a) timely and complete submission of biology samples and data, b) participation of NYUMC scientists and laboratories in studies involving cytogenetics, molecular biology and other laboratory disciplines. 5) Increasing the network of affiliated institutions relating to NYUMC so as to recruit patients for study who are currently not available for clinical trials. This includes the affiliation with Brooklyn Hospital and the recent affiliation with Maimonides Hospital- both caring for urban minority populations not otherwise participating in clinical trials.